PROVIDE A VARIETY OF CRITICAL CANCER PREVENTION INFORMATION MANAGEMENT FUNCTIONS

THE PURPOSE OF THE ACQUISITION IS TO PROVIDE A VARIETY OF CRITICAL CANCER PREVENTION INFORMATION MANAGEMENT FUNCTIONS NECESSARY TO SUPPORT THE IDENTIFICATION, DEVELOPMENT, AND QUALIFICATION OF CANCER PREVENTION INFORMATION